Community Partnership Consortium

Modified Project Summary/Abstract Section

Our Community Partnership Consortium (CPC) will organize and nurture productive and meaningful relationships with a broad cross section of stakeholders, including representation from community, local, state, and national organizations, including pregnant and postpartum women and their families, community members, trusted community- based organizations, health systems, and Government, policy, and quality improvement partners. The CPC will:
(1) Contribute to the thematic focus of the Center; (2) Create cooperative and fair partnerships between the Center and the community partners in each stage of the research process (concept, implementation, evaluation, and dissemination); (3) Use a novel, theory-based approach to dissemination that coordinates dissemination activities among community members, partner organizations, and policymakers; and (4) Translate findings into sustainable community and system-level changes locally, statewide, and nationally. The CPC will create an action-oriented, inclusive, broad-based stakeholders’ consortium to act as full partners in increasing the relevance and reach of Center activities. The CPC will engage members in promoting the utility, uptake, dissemination, scalability, and sustainability of Center findings, and building maternal health disparities research and practice capacity. Transformative change/research begins with community; community is the heart of community-based public health. The CPC will ensure that the Center has community at its heart.

CPC members include health systems, community-based organizations, and other key stakeholders. Celeste Sanchez Lloyd will serve as the health system/community lead. Ms. Lloyd currently serves as Program Manager of Strong Beginnings-Healthy Start (of Corewell Health, a large health system), is a WK Kellogg Foundation Community Leadership Fellow, and participates on several state boards focused on reducing disparities. Kent D. Key, PhD will serve as the academic lead. Dr. Key is a health disparities researcher at Michigan State University with extensive experience in community engaged research and building successful community-academic partnerships, including for NIH Centers and national organizations. In addition, the CPC brings national dissemination and implementation science expertise to the tasks of disseminating and translating Center findings, including a novel, theory-based approach to dissemination and an entire Center Project (Project 3) dedicated to advancing the science of scale-up. Our group of CPC partners is uncommonly dedicated, skilled, and connected. All of the CPC partners have expertise in, or an understanding of, the health disparities framework. Each has developed local and national partnerships and some degree of experience in health disparities research, practice, and policy. The CPC will increase capacity to build collaborations and partnerships to advance maternal health and reduce disparities. We will seek to build upon each of the partners’ networks to add relevant partners to the CPC, creating a network of networks for the Center. Center projects and public policy connections will create sustainable community and system-level changes locally, statewide, and nationally.